Identify Rare Pathogenic Variants and their Functional Consequences in SLE

Systemic lupus erythematosus (SLE) is a chronic autoimmune disease characterized by episodic flares,
significant morbidity, and higher mortality. Since >1 million Americans have SLE, the economic impact is $50
billion/year, with the most disease burden on women of non-white ancestry. Few effective treatments exist for
SLE, largely because etiology is incompletely understood, but the disease is likely to occur in genetically
susceptible individuals upon environmental triggers. Patients with childhood-onset SLE (cSLE) have more
severe and aggressive disease than those with adult-onset. While genetic investigations of cSLE could yield
important insights to SLE pathogenesis, most studies have focused on adult-onset SLE patients. We studied
two African American families, each having two sons affected with cSLE, using whole exome sequencing. In
each family, a private loss-of-function (LOF) variant of SAT1 co-segregated with the SLE disease status of the
affected sibling, exhibiting an X-linked recessive pattern. SAT1, encoding the spermidine/spermine-N1-
acetyltransferase (SSAT1), a rate-limiting enzyme in polyamine catabolism, was not known as a genetic
association with SLE. We showed disease causation of the frameshift LOF variant in CRISPR/Cas9-edited
(knock in, KI) C57BL/6 (B6) mice. Young hemizygous male and homozygous female mice spontaneously
develop lupus-like characteristics, highlighting potential monogenic contribution in multiplex families with cSLE,
an understudied resource. Here we propose to 1) apply whole genome sequencing on 30 SLE multiplex, 62
simplex families, and an additional 35 cSLE patients enriched for early disease onset (< 10-year-old), familial
aggregation, and non-European ancestry, to define polygenic risk scores of each individual and to identify
novel, ultra-rare, pathogenic coding and non-coding variants; (2) test the evolutionally conserved, pathogenic
coding variant candidates for their ability to induce either spontaneous or apoptotic cell-induced lupus in
conditional KI mice on B6 mouse background and to assess differentially expressed genes and pathways that
are altered in diseased tissues and cell types; and (3) test the functional consequences of pathogenic coding
variants from Aim 2 and predicted non-coding candidate risk alleles in differentiated human immune cells
derived from genome-edited induced pluripotent stem cells (iPSCs). Our proposed studies are likely to discover
novel monogenic lupus variants and validate causality of new and/ or prior monogenic lupus-associated
variants in isogenic non-autoimmune mice and iPSCs, which will gain insights into disease causal pathways and
pave the way for the new development of targeted therapies in disease management of patients affected with
SLE.

Public health relevance
Project Narrative While hundreds of lupus susceptibility gene variants contribute to disease risk in most lupus patients, in a very small patient population, often familial and/ or childhood-onset lupus patients, the disease is caused by a single dysfunctional gene variant, and therefore called monogenic lupus. The goals of this study are to identify new, rare variants that could explain the disease status in familial and/ or childhood-onset lupus patients and to understand their functional consequences. Given that only approximately 40 known monogenic causes for lupus, new discoveries could open doors to improve our understanding of the disease and to facilitate the development of better medications.